Advanced Imaging Methods in Pulse EPR

Abstract:
Precise partial oxygen pressure (pO2) measurements can guide therapeutic intervention in cancer and other
fields. Pulse electron paramagnetic resonance imaging (pEPRI) is an outstanding method for imaging pO2 using
the linear relationship between spin-lattice relaxation rate R1 (=1/T1) and pO2 using an oxygen-sensitive trityl
OXO71 as the contrast agent. Usually, T1 is extracted from an inversion recovery electron spin echo (IRESE)
combined with the radial acquisition imaging method. For IRESE, multiple experiments with different delays
have to be performed to capture T1-dependent spin evolution. Additionally, the IRESE imaging method requires
high RF power for pi-pulses, which makes it poorly scalable to larger objects and higher resolutions. Another
technique, single point imaging (SPI), offers higher resolution and requires lower power but is slow and
inefficient in T1 imaging. To resolve this issue and to obtain fast and precise pO2 imaging using pEPRI, we have
taken inspiration from magnetic resonance fingerprinting (MRF) and invented a pulse EPR Fingerprinting
(EPRF) method combined with the SPI acquisition strategy, named single point fingerprinting (SPF) imaging.
The SPF method utilizes a sequence of many pulses followed by signal detection after each of them. The overall
duration of the pulse sequence is comparable to the T1 relaxation time, thus forming a non-equilibrium
acquisition strategy. The relaxation times are extracted by matching experimental traces to a dictionary obtained
from the Bloch equation simulations of spin systems with different T1 and T2, corresponding to a pO2 value and
B1. In Aim One, we will establish the hardware to implement variable flip-angle sequences with bandwidth-
compensated pulses; in Aim Two, we will develop the SPF sequences and dictionary for SPF; Aim Three will
evaluate SPF with phantom experiments and with proof of concept in vivo study of fibrosarcoma and head and
neck tumor models, thus covering a range of hypoxia; Aim Four will assess an early response of radiotherapy
using SPF with a hypoxic 4T1 and a normoxic MCF-7 mouse tumor models, while also comparing the efficiency
of SPF with IRESE for animals breathing medical grade air (21% O2) and 100 % O2, thus covering a broad range
of pO2. The technique developed in this project is expected to increase the speed and spatial resolution of oxygen
imaging while reducing the RF power needed for imaging, thus making pO2 EPR imaging translatable to clinics.
The long-term goal of this project is to utilize pEPRI in clinical oximetry applications, where it can assist with
cancer treatment and evaluation of other pathologies.

Public health relevance
Narrative Pulse electron paramagnetic resonance imaging provides maps of partial oxygen pressure in tissues. However, current methods of obtaining oxygen maps are not scalable to large objects due to long acquisition times and high-power requirements. This proposal will develop a fingerprinting-based technique that can provide oxygen maps with high precision, high spatial resolution, and low power, thus making it scalable and suitable for clinical oximetry applications in oncology and other fields.